Oral Cavity and Brain Cross-talk in Alzheimer's Disease

Summary
Although Alzheimer’s disease (AD) is an age-associated neurodegenerative disease, continuing evidence
demonstrates pathophysiology outside of the brain. This suggests a more complex process of disease with
systemic manifestations as well. Numerous studies now demonstrate that changes in the oral cavity have a
relationship with AD. Human patients have elevated salivary Aβ concentrations and reported problems with
saliva flow. In addition, periodontal disease, tooth loss, and overall poor oral health are all positive risk factors
for AD. This suggests that AD and periodontal health may have a reciprocal relationship. Using two different
transgenic mouse amyloidosis models of AD, APP/PS1 and AppNL-G-F mice, we verified not only Aβ secretion in
saliva, but a unique disease-associated oral microbiome and enamel thinning and increased cavities compared
to wild type controls. Based upon these findings and prior work by others, we hypothesize that that oral cavity
changes are a peripheral manifestation of AD contributing to disease progression. We will continue using the
AppNL-G-F mouse line to fully define oral health across age and disease stage in the first aim. In the second aim
we will determine whether salivary secretion of Aβ is needed for the oral dysbiosis and decline in oral health in
the AD line. In the third aim we will determine whether the oral dysbiosis is specifically responsible for the
decline in oral health and brain presentation of disease in the mice. This study will define an innovative
mechanism demonstrating that oral cavity dysbiosis and dysfunction is a characteristic of disease which also
contributes to AD progression. We expect to find that salivary Aβ secretion contributes to oral dysbiosis and
changing the oral microbiome is sufficient to ameliorate disease presentation in the brain. This will demonstrate
a new bi-directional understanding of disease involving a mouth-brain axis.

Public health relevance
Narrative Periodontal disease has been associated with increased risk of dementia and Alzheimer’s disease although no causitive relationship has been established. Our preliminary data demonstrated the presence of Aβ peptide in saliva in an Alzheimer’s disease transgenic mouse model. This correlated with a unique profile of oral bacteria in diseased mice as well as increased numbers of cavities and enamel thinning in males. Based upon our rodent findings, it appears that Alzheimer’s disease changes are present in the oral cavity. Monitoring these changes may be useful correlates of disease progression. Alternatively, a novel mouth-brain interaction may be involved in disease progression.